Cancer Research Career Enhancement and Related Activities

PROJECT SUMMARY: CANCER RESEARCH CAREER ENHANCEMENT
As the only academic Cancer Center in its four-county catchment area (South Florida), the Sylvester
Comprehensive Cancer Center (Sylvester) has a unique responsibility to provide cancer-focused education
and training across the career continuum. Sylvester’s Office of Education and Training (OET) coordinates
these activities, ensuring they meet and exceed the needs of diverse learners, including students, pre- and
postdoctoral trainees, faculty, and healthcare professionals. Kerry L. Burnstein, PhD, Associate Director for
Education and Training leads the OET, overseeing the strategic development, coordination, and evaluation of
these efforts with assistance from Sylvester leadership and administration, Sylvester’s External Advisory
Board, and the Cancer Education Leadership Council, an internal advisory committee comprising University
leaders in education, training, and mentoring. They work together to achieve the career enhancement priorities
identified in Sylvester’s 2014-2018 Strategic Plan to 1) Build and sustain cancer research careers through
stage-specific scientific and professional development; and 2) Provide broad, crosscutting career enhancement
and educational programs that facilitate collaborative, interdisciplinary cancer research. While many of the
Center’s education and training activities are new, for the past 12 years the Cancer Biology Graduate (CAB)
Program has successfully educated dozens of promising graduate students in basic or translational cancer
research. Sylvester trainees have been productive and engaged in impactful cancer research; of the 150
publications highlighted by Sylvester’s three Research Programs, trainees were first or second author on 50%.
Recently, Sylvester members received five cancer-focused or related T32 training grants, an international U54
grant with Argentina that has a significant education and training component, and an NCI K12 Calabresi award,
which will begin enrolling physician scientists in 2019. To extend the impact of these grants, Sylvester will fund
an additional trainee for the T32s awards and the K12. Sylvester supports traditional career enhancement
activities such as distinguished lecture series, annual retreats, trainee speaking opportunities, and novel
educational strategies including a nurse practitioner oncology fellowship and opportunities for medical students
to work in medically underserved communities with cancer control experts. Given the unparalleled multicultural
and linguistic diversity of the catchment area, Burnstein and the OET work with the University of Miami Clinical
and Translational Science Institute leadership and Sylvester’s Associate Director for Population Science and
Cancer Disparity to ensure that trainees receive didactic and experiential instruction on how cancer risk and
outcome vary across populations, allowing them to consider and possibly incorporate this knowledge into their
research design. Together these efforts foster a pipeline of highly motivated healthcare professionals and
researchers, uniquely trained to solve the complex cancer-related problems in their communities and beyond.